Systematic Identification and Phenotypic Characterization of causal genetic variants in Rare Disease-Associated Birth Defects

Project Summary
Although the implementation of whole exome sequencing (WES) and whole genome sequencing (WGS) in a
clinical setting has greatly facilitated the identification of birth defect-associated genetic variants, distinguishing
the specific variants that cause congenital defects remains a major challenge. More specifically, most variants
detected in clinical sequencing occur in genes not previously associated with disease or in noncoding regions of
the genome that lack predictable functional consequences. Enhancing the ability to illuminate causal variants
holds the promise of improving the quality of life for patients and in some cases may provide a window for
therapeutic intervention that would otherwise be missed. In this proposal we leverage our institute’s unparalleled
pediatric genetic data repository to guide the development of scalable cell-based systems that, when coupled
with phenotypic validation in both animal and patient-derived organoid models, will systematically identify genetic
variants that are responsible for congenital defects in our undiagnosed rare disease patient population. We will
(Aim 1) catalog loss-of-function variants associated with the most prevalent congenital defects in our patient
population, perform genome-scale CRISPR screens in relevant organoid models to distinguish variant-harboring
genes that play a role in development, and validate the phenotypic consequences of gene loss in a zebrafish
model. In parallel, we will (Aim 2) catalog noncoding variants (i.e. intronic, putative cis-regulatory) associated
with prevalent congenital defects, develop a suite of massively parallel genomic assays capable of profiling the
regulatory impact of noncoding genetic variants at scale, and perturb the expression of candidate variant-
associated genes in a zebrafish model to determine the phenotypic consequences. Finally, we will (Aim 3)
generate patient-derived organoid models, utilize precision genome engineering in combination with single-cell
transcriptomics in patient-derived organoids to validate the causal role of specific variants in congenital defects,
and characterize the impact of variants on development using spatial transcriptomics in patient-derived
organoids as a proxy. We anticipate that the work outlined in this proposal will establish an experimental
framework that can be deployed to identify genetic variants that are responsible for a wide variety of congenital
defects.

Public health relevance
Project Narrative Although the implementation of whole genome sequencing in a clinical setting has greatly facilitated the detection of birth defect-associated genetic variants, distinguishing the specific variants that cause congenital birth defects remains a major challenge. This project aims to address current obstacles in variant interpretation through the application of innovative experimental approaches and scalable genomic technologies to profile the functional and phenotypic consequences of congenital defect-associated genetic variants identified in undiagnosed rare disease patients. These methods will rapidly accelerate the process of identifying causal variants and in some cases may reveal previously unappreciated avenues for therapeutic intervention.